Cancer Center Support Grant

PROJECT SUMMARY This supplement will continue to address African American (AA) cancer-related disparities in our catchment area by: 1) Increasing participation of AAs in prevention and screening programs, with a primary focus on colorectal cancer, 2) Increasing accrual of AAs into cancer clinical trials; and 3) Increasing donation by AAs of blood and tissue to the University of Kansas Cancer Center and MCA-affiliated biospecimen repositories. The supplement leverages our 20-year partnership with Swope, a Federally Qualified Health Center that serves a predominately AA patient population, and Truman, a safety-net hospital and the largest health care provider to AAs in our catchment area, extensive partnerships with organizations rooted in the AA community (e.g., faith- based networks, neighborhood associations, barber/beauty shops), and our 15-year history of successfully enrolling over 2,500 AAs into cancer prevention clinical trials. Together with these extensive partnerships, the Community Health Educator will build upon three critical resources at the KUCC specifically designed to support community engagement: 1) the Patient Investigator Voices Operating Together; 2) the Masonic Cancer Alliance (MCA); and 3) the KUCC’s Community Advisory Boards to implement culturally tailored, evidence- based education and outreach activities consisting of targeted media campaigns, interactive community demonstrations, health fairs, participation in small- and large-scale community events, community/researcher forums, direct referral to providers, and one-on-one education and training with existing community health workers and key stakeholders. Increasing AA participation in S2S will be accomplished through promotion at ongoing community events and specific S2S screening events organized in collaboration with the MCA and AA community partners. Accrual of AA into clinical trials will be accomplished by identifying and referring patients to five promoted clinical trials. Biobanking of AA blood and tissue will be accomplished by including repository consenting documents in promoted clinical trials, expanding the repository protocols at Swope and Truman, and hosting community collection drives. Existing data capture systems (Velos, REDCap, Epic/O2) are already in place for related activities and will be used to track, monitor, and evaluate impact of the proposed approaches. Our plan for the supplement period is highly feasible. We have successfully demonstrated our ability to educate a large number of African American men and women about clinical trials and colorectal cancer screening, as well as our ability to connect African Americans to the clinical trials that are right for them. We have adapted our materials for virtual delivery and have met or exceeded most of the goals set during the current funding period. Finally, by embedding the CHE within the outreach arm of the University of Kansas Cancer Center and securing a commitment for future support of the position, we ensure sustainability of our efforts beyond the funding period.

Public health relevance
PUBLIC HEALTH RELEVANCE African Americans bear a disproportionate share of the cancer burden. Because of this disparity, AAs are a high priority population for service and research at the University of Kansas Cancer Center. This supplement builds upon a strong foundation of existing partnerships to engage AAs in community-oriented cancer education and screening programs, with a primary focus on colorectal cancer, while also increasing engagement in clinical trials and biospecimen banking participation.